Preconceptual Bisphenol and Phthalate Effects on Early Embryonic Development

Project Summary
NYU School of Medicine, Erasmus University Medical Center and New York State Department of Health
respond to PA-16-160, proposing to study preconception and prenatal phthalate and bisphenol exposures in
relationship to time to pregnancy, embryonic and fetal growth, and infant growth. A substantial literature
suggests that a diverse array of synthetic chemicals may influence developmental endocrine programming and
provoke oxidant stress, a major pathophysiologic mechanism underlying adverse birth outcomes. These
include: phthalates (which are used to soften plastics and as scents); and bisphenols (used in aluminum can
linings and thermal paper receipts). Yet, longitudinal studies of early life exposure to phthalates and bisphenols
and their effects on fetal and postnatal growth in humans have been limited, and the few studies to date have
not yielded consistent findings. We propose to analyze samples from preconception, three timepoints in
pregnancy (7, 13 and 30 weeks) in 1000 father-mother-infant triads in Generation R Next, a prospective,
longitudinal multi-ethnic birth cohort study. Unique embryonic and placental assessments will have been
performed through repeated ultrasounds at 7, 9 and 11 weeks. These analyses will also capture embryonic
and placental growth as well as liver growth and cardiac size. The proposed study will also leverage
echocardiography and abdominal sonography performed at 1 and 12 months of age, which will assess
dimensions such as left ventricular end-diastolic volume, end-systolic volume, stroke volume, ejection fraction
and mass, as well as abdominal fat and liver steatosis. The PI (Trasande) is an internationally renowned
expert in children's environmental health and the proposed study also benefits from strong support from
Generation R Next, including the Director (Jaddoe), an experienced pediatric and perinatal epidemiologist with
a strong record in studying early determinants of cardiovascular disease. Analyses will be performed by K.
Kannan at Wadsworth Laboratories of the New York State Department of Health, who has deep experience
with precise measurement of phthalate and bisphenol biomarkers in urine. Given the long-term implications of
the “thrifty phenotype,” if preconceptional exposures are found to be important in shaping fetal growth and
influencing birth outcomes, then guidance in anticipation of conception to limit environmental exposures before
pregnancy may be indicated. Presently, such guidance is limited in the United States, save perhaps from
couples seeking advanced reproductive technology.

Public health relevance
Project Narrative Studies of phthalate and bisphenol exposure in pregnancy and their impact on growth have been limited by lack of data regarding exposures before conception and in early embryonic development. The proposed work leverages a large Dutch cohort begun before conception to examine exposures to these chemicals, especially those emerging as replacements for bisphenol A and di-2-ethyl-hexylphthalate. If preconceptional exposures are found to be important in shaping fetal growth and influencing birth outcomes, then guidance in anticipation of conception to limit environmental exposures before pregnancy may be indicated.